TO Title: Contract Orientation & Kickoff Meeting for Preclinical Services for PREVENT Base IDIQ Title: PREVENT Cancer Preclinical Drug Development Program: Preclinical Efficacy and Intermediate E

PREVENT EFFICACY Pool: This contract supports the PREVENT Cancer Preclinical Drug Development Program,
which provides a structured approach to drug and vaccine development, from discovery to the clinic. This contract is a
part of a multiple-award Indefinite Delivery Indefinite Quantity (IDIQ) pool to procure services related to Preclinical
Efficacy and Intermediate Endpoint Biomarkers, which is also referred to as the Efficacy Pool.